Towards Robust Multiplex Genome Engineering Beyond CRISPR-Cas9

Supplement Application Abstract Towards Robust Multiplex Genome Engineering Beyond CRISPR-Cas9 Recent genome-wide association studies on Alzheimer’s Diseases (AD) and related dementias have provided a rich resource of AD risk genes and variants. While this bounty of information is poised to transform neurodegeneration research, we need tools to identify and validate their functions. Genome engineering tools such as CRISPR-Cas9 are valuable for such validation, allowing precise editing of AD-related genomic variants. However, current genetic engineering approaches are limited in efficiency, scalability, and have unwanted editing errors that could confound validation experiments. Moreover, we need tools with robust activities in challenging neuroscience models, beyond editing a few cell lines. Hence, building on our existing NHGRI-funded work, we will use innovative genome technologies for studying AD and related dementias, in collaboration with experts at the Stanford Alzheimer's Disease Research Center (ADRC). Firstly, we will use computational simulation with experimentation to develop precision tools to edit human risk variants in AD models. We will leverage and further develop our novel CRISPR enzymes and RNA-to-DNA editing tools that we recently established based on work from the parent award (JACS. 2019). Secondly, we are developing error- free gene-editors via mining metagenomic recombination enzymes. These error-free gene-editors are capable of engineering up to multi-kilobase sequences in human stem cells and neurons (Wang et al., under review). We will use this accurate gene-editing methods to engineer large AD risk alleles in neurodegeneration models, and, working with expert collaborators, demonstrate in vivo editing. Thirdly, we are developing Turbo-seq, a single-cell perturb-seq platform leveraging machine-learning algorithms and our multi-target CRISPR screen tool for AD studies (Hughes et al., submitted). We will apply Turbo-seq to simultaneously engineer single and multiple AD-associated variants in relevant disease models, with an initial focus on APOE alleles and related protective (or causal) variants. We will determine the functional consequences when genetically engineering these AD variants compared with healthy controls, integrating single-cell profiling of RNAs and proteins. Our multi-target, scalable CRISPR tools will significantly accelerate functional study of neurodegeneration variants when considering the large number of candidates, existing and from our collaborators’ work with the Stanford Extreme Phenotypes in AD (StEP AD) cohort, and help identify potential interactions between risk alleles. Overall, our plan is to build a gene-editing and single-cell toolkit, with an accompanying data- analysis pipeline for neurodegeneration research, thereby expanding the parent award’s tool-building and resource-sharing efforts into this new focus with the supplement.

Public health relevance
Project Narrative Towards Multiplex Precision Genome Engineering Technology Beyond CRISPR As medicine advances to unravel mechanisms of complex human diseases such as neuro- degeneration, a remaining challenge is that our knowledge of the genetic and epigenetic basis of these disorders are often limited to small genome changes like single-nucleotide variants. The key bottleneck for uncover these genome black boxes is the lack the precision tools to study large genome changes. Thus, it demands new modalities of multiplexable and accurate genome engineering tools that we proposes to develop here, leveraging advances in computational modeling and genome editing, to push our ability to engineer, track, and control cellular genome, with Alzheimer’s Disease model as initial test ground.